Leadership, Planning and Evaluation

Abstract: Leadership, Planning and Evaluation
UPMC Hillman Cancer Center’s (HCC) planning and evaluation activities are well-developed and provide
invaluable guidance to the HCC Senior Leadership Team (SLT): Director (Robert L. Ferris, MD, PhD), HCC
Deputy Director (Edward Chu, MD), Deputy Director for Research Administration (Chad A. Ellis, PhD) and the
Associate Directors for Basic Research (Shivendra Singh, PhD), Clinical Research (Antoinette Wozniak, MD),
Population Sciences (Jian-Min Yuan, MD, PhD), Training and Education (Christopher Bakkenist, PhD),
Catchment Area Research (Margaret Rosenzweig, PhD, CRNP-C, AOCN, FAAN), and Health Equity and
Community Outreach & Engagement (Linda Robertson, RN, MSN, DrPH). Individually accomplished, with
strong scientific and leadership achievements, they work collectively as the SLT HCC’s primary decision-
making body for setting the Center’s overall strategic direction. The SLT provides direction in issues relevant to
HCC operations, management, and policy, and oversees all research activities. This leadership team also sets
budgetary and fiscal priorities and reviews HCC membership.
In addition to the SLT, several key internal and external governance structures provide the primary means by
which the HCC conducts ongoing planning and evaluation: the Research Executive Advisory Committee
(REAC), Shared Resources Oversight Committee (SROC), Clinical Research Oversight Committee (CROC),
Committee for Health Equity and Community Outreach & Engagement (CHECOE), Committee for Excellence
in Cancer Education and Training (CECET), Facilities and Common Equipment Committee (FACE), and the
Internal and External Advisory Boards. The REAC includes the SLT, Program and Shared Resources
leadership, and key senior HCC members, and is an effective mechanism for information exchange among
HCC stakeholders and serves as the primary forum for strategic planning. The External Advisory Board (EAB),
comprising recognized leaders in basic, clinical, translational and population sciences, and cancer center
administration, meets at least annually to review all aspects of HCC operations and new initiatives. Since his
appointment, Dr. Ferris augmented EAB membership to better align with HCC scientific priorities and goals.
Additional planning input is provided by retreats, other Center advisory committees, surveys and ad hoc
external reviews.
With careful planning and critical input from the different advisory groups, HCC leadership initiated an
important strategic visioning and planning process, reorganized the research program structure, and created
new committees to continuously improve oversight and governance. These coordinated teams provide critical
advice and guidance, ensuring that the HCC effectively sets priorities and pursues objectives that promote its
mission.